Administrative Core

ADMINISTRATIVE CORE ABSTRACT
The overarching goals of the Administrative Core are to coordinate and integrate all activities of the Center,
including core reporting, P/F administration and enrichment activities. Towards these goals the WU-RDRRC
proposes the following aims:
1) Promote awareness of the resources within the Center to foment interest in rheumatic diseases
research through collaborative, trans-disciplinary activities across the WU community, organize and
align Core laboratories and services to provide state-of-the-art technologies and specialized resources
in line with members' needs.
2) Enhance synergies between RDRRC and other WU funded Centers conducting rheumatic disease-
related research as well as extramural institutions in the Midwest
3) Identify and nurture the careers of junior faculty interested in rheumatic diseases research
4) Establish a Multidisciplinary Research Expert Panel (Research Forum) to provide guidance for new and
junior faculty in the planning and execution of research projects
5) Support educational seminar series that bring together scientists within and outside WU campus to
communicate their newest ideas or research in rheumatic diseases
The leadership of the WU-RDRRC will provide consistent and strategic oversight guided by an Internal
Executive Committee (IEC) and a Center Advisory Board (CAB) comprised of internal and external board
members. We will develop formal metrics to measure Core performance and WU-RDRRC impact through the
evaluation of scientific network activities, outputs and implementation.